Harnessing gut microbiota to reduce inflammation using broccoli-sprout diets

Project Summary
Inflammatory bowel disease (IBD) is a poorly understood gastrointestinal (GI) condition
characterized by inflammation. The prevailing theory is that combined genetic and environmental
factors disrupt the host immune system’s interaction with gut microbiota. Our central hypothesis
is that consumption of specific broccoli sprout preparations elicits changes in the gut microbiota
that not only improve the production of anti-inflammatory bioactives, but also promote intestinal
homeostasis. Our labs have shown there is an anatomical pattern along the GI tract where
broccoli sprout-derived bioactive levels are high which correspond to diet-induced changes in gut
microbial communities. We showed that gut microbiota contribute to the transformation of inactive
precursors to bioactives, and that specific broccoli sprout preparations alter their capacity for
biotransformation, and the susceptibility of mice to colitis. However, a significant knowledge gap
remains regarding the mechanisms by which dietary bioactives modify disease risk and the role
of gut microbiota. Our immediate goal is to identify the mechanisms by which broccoli sprout diets
affect susceptibility to IBD in mice. Our long-term goal is to develop a dietary preparation of
broccoli sprouts which has therapeutic effects against IBD in humans. Our innovative approach
uses different preparations of broccoli sprouts to help differentiate gut microbiota versus plant-
derived enzymatic activities. We employ a combination of “omics” approaches to spatially-map
the microbial community and metabolite profile changes along the GI tract, to better assess
changes induced by broccoli sprout diets. We complement “omics” approaches with culturing,
and validate our study design using two complementary models for strategic research. Aim 1
tests the hypothesis of an anatomical pattern where the GI tract microbiota transform broccoli
compounds into bioactives, and helps us determine whether this microbial biotransformation is
sensitive to dose of broccoli compounds. We will use our established DSS-mouse-model of
ulcerative colitis to investigate the effects of different broccoli sprout preparations and
concentrations on the microbiota along the GI tract; on the resulting concentration of bioactives
in gut tissues; and on the development of colitis in mice. Aim 2 tests the benefits of using an
immunosuppressed mouse model in the dietary prevention study to provide a stronger
translational strategy for the use of broccoli sprouts for IBD prevention. When exposed to a
specific bacterial pathogen, the immunosuppressed mice develop chronic enterocolitis
resembling Crohn’s disease. This diet-based approach provides critical information for developing
accessible and equitable strategies for improving health of IBD patients.

Public health relevance
Project Narrative This project will investigate how consuming differently-prepared broccoli sprout diets impact bacteria in the digestive tract, and how those bacteria transform specific compounds in broccoli sprouts into bioactive compounds which can reduce inflammation related to Inflammatory Bowel Disease (IBD). We will use complementary mouse models to study the effect of broccoli sprouts on microbial community composition, on the production of bioactive compounds, and on inflammation and disease progression in mice. This research will have significant impact by developing dietary- and microbiome-based strategies to reduce susceptibility to colitis, which may significantly improve disease outcomes and quality of life of patients afflicted with IBD.